Brain Tissue Resource Center for Alcohol Research

Project Summary
Alcohol-related disorders are areas of major public health and socio-economic concern. Research
aimed at preventing addiction and organ damage, especially alcohol-related brain damage (ARBD),
must be underpinned by a sound knowledge of the biology of alcohol misuse at a cellular level. Such
research is dependent on access to high quality, extensively characterized tissue from individuals with
alcohol use disorders and matched controls. The NSW Brain Tissue Resource Center (BTRC) is a
brain bank that was established to facilitate research into alcohol addiction and ARBD. It provides
human post-mortem brain tissue, and associated clinical information, to researchers worldwide.
Tissues are collected from individuals with alcohol use disorders and controls through a prospective
donor program or from people undergoing forensic autopsy. Collection of tissue is closely monitored
using a range of inclusion and exclusion criteria so as to maintain tissue quality for application to a
wide variety research techniques. Tissues are prepared so that fresh frozen, formalin fixed and
formalin fixed, paraffin embedded samples are available to researchers. Cases undergo a thorough
neuropathologic examination and are assigned DSMIV and DSM 5 diagnoses following review of
medical records and medical, family history and lifestyle information provided by the donor and/or their
family. Cohorts of alcoholics and controls with and without complicating factors (e.g. comorbid
cigarette smoking, liver disease or depression) are then established to allow researchers to tailor their
study design to address questions of importance for alcohol misuse and alcoholism. Access to tissue
is open to any researcher with institutional ethics approval. Requests for tissue are reviewed by an
NIAAA convened Scientific Review Board to ensure appropriate and efficient use of the resource. The
BTRC holds institutional ethics approval to collect, hold and distribute tissues and associated clinical
data. Its operations are overseen by a Director, Professor Jillian Kril, Deputy Director, Dr Greg
Sutherland, and Manager, Ms Donna Sheedy, all of whom have extensive experience in biobanking
and have, over their careers, contributed more than 70 publications in the area of alcohol research. A
Management Committee appointed by the University of Sydney provides oversight and guidance to
the BTRC. The University of Sydney provides the infrastructure to house and operate the bank. Since
its inception in 2000 the BTRC has facilitated over 110 research projects that have resulted in 207
publications on various aspects of alcohol misuse and alcoholism. In addition, projects have
contributed to the research degrees of 194 students. The BTRC also contributes tissue and data to
research projects on other aspects of neurological and psychiatric disease that have resulted in an
addition 300+ publications.

Public health relevance
Project Narrative The NSW Brain Tissue Resource Center provides well characterized, high quality tissues and associated clinical and lifestyle information to researchers worldwide. Human post-mortem brain tissue is an essential resource to study the molecular and cellular basis of addiction and alcohol-related brain damage. In addition, tissue based studies augment clinical and preclinical studies and facilitate translation of research findings into better diagnosis and treatment of patients.